GENETICS FACTORS IN PATIENTS AT HIGH RISK OF CANCER--ROU

Utilize cytogenetic and genetic marker analysis of blood and tissue specimens from patients and families at high risk of cancer to identify genetic variation that increases cancer susceptibility.